Determine the Clinical Effectiveness of MobileCentering Pregnancy to Improve Maternal and Infant Health Outcomes of Marshallese in Arkansas

Pacific Islanders have high obesity rates compared to other individuals in the United States (US) population. Pacific Islanders residing in the US also have poor maternal and infant health outcomes including high rates of preterm birth (<37 weeks) and low birthweight infants (<2,500 grams). They are also more likely to experience preeclampsia, primary cesarean birth, excessive gestational weight gain, gestational diabetes mellitus, and low exclusive breastfeeding rates compared. These health circumstances increase medical complications and are associated with impaired glucose intolerance, delivery complications, and higher incidence of obesity and metabolic disease risk later in life for infants. Early and consistent supportive care throughout the pregnancy continuum is strongly associated with positive birth outcomes that can mitigate childhood obesity.

However, Pacific Islanders are less likely to receive adequate prenatal care. Our preliminary studies using Arkansas birth records (n=2,488; 2019) have shown that Marshallese experience exceptionally poor perinatal outcomes. Specifically, 15% of Marshallese women received no prenatal care (compared to 1.6% women nationally); more than 50% do not attend the recommended number of prenatal care visits; 19% of Marshallese infants were born preterm (compared to 9.6% nationally); and 15% of Marshallese infants were low birthweight (compared to 8.3% nationally). These poor health outcomes are highly associated with childhood obesity risk through increased odds of rapid infant weight gain and sub-optimal infant feeding practices. CenteringPregnancy, an evidenced-based group prenatal care model, challenges the standard model of one- on-one prenatal counseling and has demonstrated effectiveness in improved health outcomes.

Public health relevance
The proposed study will determine the preliminary effectiveness of an innovative Mobile CenteringPregnancy program for Marshallese women to inform sustainable scaling of the program.